Body MRI: Unsolved Problems & Unmet Needs

Workshop Title: “Body MRI: Unsolved Problems & Unmet Needs”
Workshop Overview and Aims
Functional body MRI biomarkers are underused in research and clinical practice due to the need
for dedicated in-house expertise and development. Transferring solutions to other centers is
therefore a challenge, leading to a significant duplication of efforts, a lack of standardization in
the methods, and difficulties in comparing results between centers. This also limits commercial
buy-in, hinders the set-up of multi-center trials, and overall slows down their translation into
clinical practice.
The proposed workshop aims to bridge this gap. The purpose of this workshop is to bring
together internationally recognized scientists and clinicians along with new investigators who
are currently developing and applying advanced renal MRI techniques to investigate the causes
and consequences of body diseases.
The program of this workshop integrates clinical presentations outlining the needs for non-
invasive testing and biomarkers and covers advances in contrast-based MRI, new applications
of relaxometry, diffusion, and elastography, and application of Artificial Intelligence techniques.
We intend to include interactive sessions.
With an important focus on the next generation, the workshop will include mentoring sessions
for trainees and new investigators, called “Meet the Experts”. These mentoring sessions will
provide specific information on clinical trials design, funding and regulations, as well as a
hands-on “How-to” session on available imaging post-processing software.
A previous NIDDK supported ISMRM workshop on Renal imaging held in September 2021 was
attended in-person by 80+ attendees. Thus, we expect robust interest in the community for the
proposed workshop.

Public health relevance
Narrative The workshop is designed to bring together clinicians, technologists, and MR scientists committed to advancing the field of body MRI. The meeting aims to discuss and address unmet needs in clinical body MRI. This meeting will be a forum to exchange ideas, share knowledge and positively impact to future direction of body MRI. The emphasis will be on engagement, team building, team science, networking, and connecting with others in the Body MRI community.